The Role of Egfl6 in Tumor Immunity

Ovarian cancer (OvCa) has an extremely high mortality rate, indicating a clear need for new therapeutic
approaches. One such approach is immune checkpoint inhibitor (ICI) therapy. Unfortunately, despite the
presence of anti-tumor effector cells in many OvCa patients, ICI therapies have poor response rates in OvCa.
One reason for this may large numbers of immunosuppressive myeloid-derived suppressor cells (MDSCs) and
tumor-associated macrophages (TAMs) present in the OvCa. Both MDSC and TAM negatively regulate immunity
in cancer and therapeutic approaches which can disrupt the recruitment/function of these cells can enhance ICI
response. A potential therapeutic target to disrupt MDSC/TAM is Egfl6. Egfl6 is a developmental growth factor
which is known to regulate cellular migration, proliferation, and differentiation and is highly expressed in OvCa.
We found that mice which overexpress Egfl6 have increased numbers of granulocytes and monocytes in both
the bone marrow (BM) and spleen. Egfl6 treatment of BM myeloid cells was associated with an integrin
dependent increase in p-Syk, and differentiation to IL-10+ and S100A9+ granulocytic MDSC. Murine tumors
which overexpress Egfl6, compared to controls, (i) have a significant increase in MDSC accumulation and M2-
like TAM, (iii) express CXCL2 and CLEC5a, factors associated with neutrophil extracellular traps (NETs)
formation, and (iii) are refractory to ICI therapy. We thus hypothesize that Egfl6, via Syk activation, promotes an
immunosuppressive TME by increasing numbers of MDSC/TAM and their production of NETs in tumors. As an
extension of this, we hypothesize that inhibition of Egfl6, will enhance the efficacy of ICI therapy. To test our
hypotheses, we propose: SA1. To evaluate the requirement for Syk in Egfl6 signaling on myeloid cells. As Syk
is required for integrin signaling in granulocytes, we hypothesize that targeted disruption of Syk will prevent Egfl6-
dependent granulocyte accumulation. Using specific Syk inhibitor compounds and Syk-KO
granulocytes/monocytes, we will dissect the Egfl6-Syk regulatory axis. SA2. To analyze the role of Egfl6 in NETs
formation and resistance to ICI therapy. We found Egfl6 expressing tumors have increased levels and NETosis
and that Egfl6 induces CXCL2 and CLEC5a, factors associated with NETosis. This occurs both in the presence
and absence of ICI therapy. We hypothesize that Egfl6, by induction of NETs, limits the anti-tumor immunity
promoting resistance to ICI therapy. We will use CXCL2 and CLEC5a mediated inhibition/KO approaches to
define the mechanisms by which Egfl6 induces NETosis and the impact of Egfl6 induced NETosis on ICI cytotoxic
immunity. SA 3. Evaluate the impact of Egfl6 neutralizing antibody on the efficacy of ICI therapy and anti-tumor
immunity. We will use an immune competent ICI responsive murine OvCa model to evaluate the ability of an
Egfl6 neutralizing antibody to overcome Egfl6 mediated immune suppression. Combined these studies will
characterize a novel mechanism of OvCa mediated tumor immune suppression and validate EGFL6 antibody as
a novel therapeutic approach to enhance ICI therapy in OvCa patients.

Public health relevance
The ovarian TME is characterized by large numbers of immunosuppressive myeloid cells that reduce the effectiveness of current immunotherapies. Our data suggest that EGFL6, a protein secreted by OvCa cells, drives an accumulation of immunosuppressive myeloids cells cells in the tumors and inhibits the activity immune checkpoint inhibitor therapies. In this study, we will determine the mechanisms of EGFL6 immunoregulatory activity and evaluate the efficacy of EGFL6 neutralization as an adjuvant to immunotherapy.